One-shot morphologic, hemodynamic and metabolic MR imaging of brain tumors

PROJECT SUMMARY/ABSTRACT:
The goal of this project is to validate a clinically feasible, one-shot contrast-enhanced, multiparametric MRI
approach for mapping the morphologic, hemodynamic and metabolic features of brain tumors using a single
contrast agent. Contrast-enhanced (CE) MRI is the clinical imaging standard for guiding nearly all aspects of
brain tumor management, including surgical biopsy/resection, radiation treatment planning, and post-treatment
surveillance for response assessment. Dynamic susceptibility contrast (DSC) MRI is a complementary
technique that leverages the dynamic passage of the contrast agents utilized for CE-MRI in order to provide
maps of tumor perfusion. An unmet clinical need in the assessment of tumor pathophysiology is the ability to
routinely detect hypoxia and its evolution. Brain tumors exhibit considerable hypoxia which leads to therapy
resistance, triggers more aggressive and invasive phenotypes, is considered a potential therapeutic target, and
is prognostic of overall survival. The most widely used method for interrogating hypoxia in the clinic relies on
PET radiotracers, which, in the context of brain tumors, necessitates multiple scans and injections in addition
to routine CE-MRI and DSC-MRI. This limitation increases costs, dose and patient discomfort, while reducing
efficiency and the likelihood of widespread use, particularly in non-academic community hospitals where
patients are unlikely to undergo multi-modality imaging. Consequently, an MRI-based hypoxia imaging
approach could significantly enhance the metabolic characterization and therapeutic management of brain
tumor patients. We have developed a GdDOTA monoamide conjugate of 2-nitroimidazole (a well-established
hypoxia binding moiety), termed GdDO3NI, that enables detection of regional hypoxia. We hypothesize that
CE-MRI, DSC-MRI and hypoxia data can be acquired in brain tumors in a single imaging session following a
single-injection of GdDO3NI and can help predict outcome of hypoxia targeted therapy. We anticipate that
optimal acquisition and analysis protocols for dynamic GdDO3NI MRI will provide hypoxia maps that regionally
colocalize with pimonidazole IHC and FMISO PET and will provide congruous estimates of hypoxic tumor
fraction between the various techniques. Towards this end we propose to 1) validate GdDO3NI based CE-MRI
and DSC-MRI in orthotopic, human-derived glioma preclinical models, 2) establish optimal GdDO3NI based
hypoxia mapping protocols and validate using immunohistochemistry (IHC) and clinically comparable PET
markers and 3) demonstrate the potential of GdDO3NI to predict response to a hypoxia activated prodrug,
evofosfamide. Our innovative, one-shot, multi-parametric strategy represents a transformational shift in brain
tumor imaging that could enable personalized therapy based on lesion morphology, regional perfusion and
metabolic heterogeneity. The proposed one-shot strategy could also be translated to cancers outside the brain,
increasing the range of patients impacted by this research and feasibility of translating GdDO3NI to the clinic.

Public health relevance
Project Narrative The proposed research is relevant to public health because it aims to validate and apply a practical, integrated imaging approach for tumor imaging that will reduce patient costs and discomfort while enabling a more comprehensive assessment of tumors. This project is relevant to NIH’s mission as it focuses on a significant technological and clinically meaningful refinement in brain tumor imaging methodology that could enable personalized therapy based on lesion morphology, regional perfusion and metabolic heterogeneity.